Using CRISPR screening to uncover aneuploidy-specific genetic dependencies

Project Summary
Aneuploidy is a cellular state in which cells contain extra or missing chromosomes. Over 90% of solid tumors
are aneuploid. Aneuploidy has been shown to contribute to drug resistance and metastasis, and aneuploid
cancers have a worse patient survival rate than euploid cancers. Despite aneuploidy’s role in cancer, aneuploidy
itself causes growth defects and induces several ongoing stressors within the cell. Gaining or losing
chromosomes leads to transcriptomic and proteomic stress, metabolic deregulation, an altered secretome, and
induces further chromosome mis-segregation. We hypothesize that aneuploidy-induced cellular stresses can be
targeted to specifically eliminate aneuploid cells, and we aim to discover genetic dependencies that are specific
to aneuploid cells. We will use CRISPR to screen multiple near-euploid human cell lines and aneuploid clones
that we derive from these near euploid cell lines. We will then compare the effect of aneuploidy on gene
dependency, independent of cell line-specific effects. Toward this goal, we have generated 54 aneuploid clones
from nine near euploid human cancer cell lines, and we have access to an additional ten aneuploid clones from
two human cell lines. We will screen these aneuploid clones, and their near-euploid controls, with a domain-
specific CRISPR library. This library targets multiple druggable protein domains, including all kinase,
ubiquitinase, transcription factor, epigenetic modulator, “royal family” epigenetic factor, protease, and ubiquitin
ligase genes. In preliminary work, we have screened multiple euploid and aneuploid cell lines with a smaller
kinase domain-focused CRISPR library, and we identified several potential aneuploid-specific dependencies.
More aneuploid cancer cell lines and their corresponding controls will be screened to confirm these potential
hits. Cancer aneuploidy is not entirely random, as specific chromosome gains and losses are selected for in
certain cancer types. In addition to uncovering general aneuploid dependencies, we aim to uncover chromosome
specific dependencies. Once we have uncovered potential aneuploidy dependencies, we will validate their
aneuploid-specificity, and then we will use cDNA to rescue gene knockout and rule out off-target effects. We will
use IP mass spectrometry to uncover any differences in hit protein binding between euploid and aneuploid
conditions, or to identify the protein binding partners of poorly characterized genes. Next, we will perform RT-
qPCR and IF to screen for aneuploidy-associated phenotypes including chromosome missegregation, proteomic
stress, senescence, and apoptosis. Additional follow up experiments will be performed to uncover their
aneuploidy-targeting mechanisms and better understand the targetable stressors induced by aneuploidy. During
this period I will be trained in CRISPR screening, bioinformatic analysis, and mass spectrometry techniques.
Aneuploid dependencies and chromosome-specific aneuploid dependencies could serve as promising targets
for aneuploid-cancer therapeutic development.

Public health relevance
Project Narrative Aneuploidy is a cellular state in which cells contain extra or missing chromosomes. 90% of solid tumors are aneuploid, and aneuploidy has been shown to contribute to drug resistance, metastasis, and worse patient outcomes. The goal of this project is to use CRISPR screening to uncover aneuploidy-specific genetic dependencies that will serve as promising targets for therapeutic development.